Establishing MAGE-A4/RAD18 as a novel cancer-specific chemotherapeutic target

SUMMARY
There are fundamental gaps in our understanding of how cancer cells acquire DNA damage-tolerance and
evade chemotherapy (termed ‘chemoresistance’). The gaps in our knowledge of DNA damage tolerance (and
how it differs between normal and neoplastic cells), limit our ability to kill tumors without causing side effect
toxicities to normal healthy tissues. Our long-term goals are to solve the problem of how neoplastic cells
tolerate therapy, and identify new molecular vulnerabilities that can be specifically targeted for improved
treatment. The objective here is to define a novel tumor-specific mechanism of chemoresistance and to
establish its tractability as a therapeutic target. Remarkably, we discovered that Melanoma Antigen-A4
(MAGE-A4, a Cancer/Testes Antigen or 'CTA') is an activating binding partner of the DNA repair protein
RAD18 (an E3 ubiquitin ligase). MAGE-A4 is absent from all normal somatic cells but pathologically activates
DNA repair in cancer cells. MAGE-A4 also activates the E3 ligase TRIM69 which confers resistance to mitotic
spindle poisons. MAGE-A4 expression is associated with poor patient prognosis yet its potential impact on the
responsiveness of tumors to chemotherapy in a physiological setting is untested. Based on exciting and
compelling preliminary studies, we will test the central hypothesis that MAGE-A4 pathologically reprograms
ubiquitin signaling in tumors to confer chemoresistance to genotoxins and spindle poisons. The rationale is
that defining the contribution of MAGE-A4 to chemoresistance will allow extraordinarily specific therapeutic
strategies that target a unique molecular vulnerability of neoplastic cells. The Specific Aims are: SA1 Define
contribution of pathologically-activated DNA repair to chemoresistance in vivo. SA2 Establish chemical
tractability of MAGE-A4/RAD18 as a therapeutic target. SA3 Mechanistically define MAGE-A4/TRIM69
functions in mitotic progression and resistance to spindle poisons. In SA1 We will use a new transgenic
mouse and orthotopic lung cancer models to determine how MAGE-A4/RAD18 impacts responses to
chemotherapy in vivo. In SA2 we will screen peptide phage display libraries to identify sequence motifs that
bind MAGE-A4 and disrupt the MAGE-A4/RAD18 interaction. Bioactive MAGE-A4 inhibitor peptides will be
tested for anti-neoplastic activity. In SA3 we will define a novel role of MAGE-A4 in regulating TRIM69 and
conferring resistance to spindle poisons. We will mechanistically define the MAGE-A4/TRIM69 signaling
pathway and establish its role in tolerance of therapeutic taxanes. These experiments will likely establish
MAGE-A4 as a druggable target for ameliorating chemoresistance in cancer cells, serving as a crucial gateway
in the drug discovery process. The proposed ideas and research are innovative because they are the first
studies to test how biological activities of CTAs affect cancer therapy. The proposed work is significant
because it will provide new paradigms for chemoresistance due to pathological ubiquitin signaling leading
directly to novel targeted therapies for chemoresistant cancer.

Public health relevance
NARRATIVE The proposed research is relevant to public health because defining cancer cell-specific pathways of DNA damage tolerance will further our understanding of how cancer arises and provide new drug targets for specific killing of tumor cells by therapeutic agents. The proposed research is relevant to the part of NIH's mission that pertains to developing fundamental knowledge that will help reduce and treat cancer.